Inflammatory Responses, Fibrotic Mediators, and Comorbidity Burden as Determinants of Myocardial Dysfunction and Heart Failure in Rheumatoid Arthritis

Project Summary
Rheumatoid arthritis (RA) is a common autoimmune disease characterized by joint inflammation and damage
as well as systemic manifestations including cardiovascular disease that lead to premature mortality. People with
RA suffer up to a 2-fold increased risk of heart failure (HF), among the most burdensome chronic conditions and
the most common cause of hospitalization in the U.S. This heightened risk of HF in RA, including HF subtypes
with preserved and reduced left ventricular ejection fraction, has not improved despite substantial RA treatment
advances over the last two decades. The mechanisms propagating HF risk in RA are poorly understood,
prohibiting the development of effective strategies to improve HF-related outcomes in RA. Given the rising
prevalence of HF in an aging population and the concerning persistence in RA-related HF risk, a critical need
exists to identify unique drivers of HF development in RA to serve as priority targets for the design of HF
prevention and management strategies in this high-risk patient population. The overall objective of this study
is to identify molecular determinants and epidemiologic mediators of early myocardial dysfunction and clinical
HF in RA, while completing a robust training program in prospective cohort development, cardiac phenotyping,
and causal inference methodology. The central hypothesis is that RA-related dysregulation in cytokines,
adipokines, and matrix metalloproteinases (MMPs) contributes to early myocardial dysfunction and potentiates
the impact of comorbidity development on clinical HF onset. In Specific Aim 1, the PI will initiate a new,
prospective RA cohort with comprehensive cardiac risk stratification, biospecimen collection, and deep cardiac
phenotyping using speckle-tracking trans-thoracic echocardiogram and paired cardiac magnetic resonance
imaging to investigate RA-related biomolecular alterations underlying subclinical myocardial dysfunction. The
hypothesis in Aim 1 is that disproportionate increases in circulating interleukin (IL)-1, IL-6, adiponectin, and
MMPs in RA will associate with subclinical myocardial dysfunction as indicated by worsened systolic and diastolic
dysfunction, valvular heart disease, and myocardial infiltration. In Specific Aim 2, the mediating effect of
comorbidity development on clinical HF and HF subtypes will be quantified through causal mediation analyses
in a national cohort of RA patients and matched non-RA controls. Further, the independent and combined effects
of comorbidity with RA-related risk factors on HF risk will be examined in an ongoing, multicenter, prospective
cohort of >3,500 RA patients. The hypotheses in Aim 2 are that 1) obesity, diabetes, hypertension, chronic lung
disease, and valvular heart disease will mediate excess HF risk in RA, and 2) RA-specific factors interact with
these comorbidities to potentiate HF risk in patients with RA. Impact: Successful completion of this study will
identify high-priority, modifiable risk-factors for myocardial dysfunction in RA and inform the development of
personalized HF prevention and management strategies in RA. Moreover, this mentored research will develop
the PI into an independent, patient-oriented investigator focused on improving CVD outcomes in RA.

Public health relevance
Project Narrative Despite advances in the treatment of rheumatoid arthritis (RA), a heightened risk of heart failure (HF) and HF- related death persists among people with RA, owed to an incomplete understanding of the inflammatory pathways and comorbid conditions underlying HF in RA. In this study, the effects of inflammatory and fibrotic mediators on subclinical myocardial dysfunction will be identified in a new, prospective RA cohort led by the PI while the impact of comorbidity development on clinical HF onset will be determined using complementary large, real-world data. The results of this study will inform the development of personalized HF prevention and management strategies in RA.